Development and validation of age-relative measures of biochemical intervertebral disc health

PROJECT SUMMARY
The link between intervertebral disc degeneration and chronic low back pain (cLBP) is widely acknowledged
but poorly understood. Emerging evidence suggests that early deficits in disc health increase cLBP risk, but
this potentially important association is difficult to study because conventional imaging methods for quantifying
disc health are qualitative, subjective, and insensitive to early deficits in disc health. Spin-lock T1ρ MRI, which
is sensitive to disc biochemical composition, overcomes this limitation. Indeed, we recently found that T1ρ
biomarkers of disc health in cLBP patients were distinct from the normal age-course of disc degeneration in
asymptomatic controls. This led to the discovery of a new cLBP phenotype that’s not apparent with
conventional MRI: young adult patients (20–40-year-olds) who have abnormal disc biochemical composition for
their age. What’s more, this T1ρ biomarker of poor age-relative biochemical disc health — what we term a low
T1ρ “Z-score” — predicts the development of new disc pathologies and associates with earlier onset of
symptoms. A critical unknown is the etiology of low T1ρ Z-scores and whether poor age-relative disc health
reflects lower peak disc health before skeletal maturity or a faster decline in disc health after. It’s also unknown
if this T1ρ biomarker predicts clinical outcomes and stratifies future cLBP risk better than conventional MRI.
Three complementary aims are proposed. In Aim 1 we’ll perform T1ρ MRI in 10–25-year-old subjects to
discover the age-course of biochemical disc composition. Specifically, we’ll determine population variability in
peak disc health and clarify whether early deficits in disc health reflect a lower peak before skeletal maturity or
a faster decline after. In Aim 2 we’ll discover risk factors for early deficits in biochemical disc health using an
innovative two-stage approach. In the first stage, we’ll conduct a meta-GWAS of adults with standardized
measures of structural disc degeneration. The result will be a multi-ethnic, genome-wide polygenic risk score
(PRS) for genetic propensity to disc degeneration. In the second stage, we’ll genotype the young subjects in
Aim 1 and test if the genetic propensity to structural disc degeneration in adulthood associates with early
deficits in biochemical disc health. Specifically, we’ll test if PRS associates with age-adjusted T1ρ values and
how the association depends on sex and anatomic risk factors, e.g., lumbar lordosis. In Aim 3, we’ll leverage
access to previously acquired spine MRIs (T1ρ and conventional), brain fMRIs, functional measurements,
psychosocial profiles, and 24-month clinical outcomes in an ongoing surveillance study of 300 adult cLBP
patients and 75 controls. This will enable us to test for associations between T1ρ Z-scores and cLBP status
and to discover how changes in pain and disability from baseline depend on a variety of patient characteristics,
including metrics from T1ρ and conventional MRI. Through these studies, we will establish a quantitative
diagnostic framework for contextualizing disc degeneration in relation to cLBP risk that could eventually
improve clinical management of cLBP and help shift clinical paradigms from reactive to preventative.

Public health relevance
PROJECT NARRATIVE Emerging evidence suggests that early deficits in lumbar disc health increase the risk of chronic low back pain (cLBP), but current methods for quantifying disc health and guiding clinical management are qualitative, subjective, and insensitive to early deficits in disc health. The goal of this project is to develop and validate quantitative, objective imaging biomarkers of early deficits in lumbar disc health that can be used to contextualize disc degeneration in relation to cLBP risk. To accomplish this goal, this project will measure population variability in the age-course of disc health, uncover risk factors for early deficits in disc health, and establish the prognostic value of these imaging biomarkers for predicting clinical outcomes.